The Role of End Synapsis Factors During Telomere Dysfunction

Proliferative barriers are key tumor suppressive mechanisms and includes cellular senescence and
replicative crisis. Telomere dysfunction (e.g., telomere shortening or telomere deprotection) plays a critical role
in such barriers, such that cells with disrupted telomeric ends can induce cellular senescence. If cells bypass
senescence, they enter the second proliferative barrier called replicative crisis. Many cells succumb to cell death
at this stage, however cells that survive crisis are prone to malignant transformation. Therefore, characterizing
the mechanisms behind telomere dysfunction is significant to give insight into the factors that drive cancer
initiation and progression. This proposal will focus on understanding aspects of telomere dysfunction and
replicative crisis, including the mechanisms behind telomere fusions and how they affect cellular survival during
replicative crisis. Aim 1: Define the role of DSB DNA end synapsis factors during telomere fusions. Telomere
fusions are a marker of telomere dysfunction and are mediated by the DNA double strand (DSB) repair pathways
Canonical Non-homologous end joining (C-NHEJ) or the Alternative End Joining (Alt-EJ). A key aspect of DNA
DSB repair is the synapsis of two DNA ends, however the mechanisms of DNA end synapsis for telomere fusions
remain poorly understood. Recent work has uncovered a possible crosstalk between C-NHEJ and Alt-EJ for
telomere fusions, and I posit that preparation of DNA DSB ends for EJ repair by both pathways involves synapsis
via DNA-PKcs, XLF, or 53BP1 to promote telomere fusions. Furthermore, I posit that these synapsis factors may
show close interactions with factors in the Alt-EJ pathway within the cell. In performing this research, I will expand
my scientific skill set in several ways, including learning microscopy methods to assess EJ outcomes by
examining types of telomere fusions. I will also use protein-protein association assays to assess interaction
between C-NHEJ and Alt-EJ factors. Lastly, I will also examine how loss of end synapsis affects DNA end
resection by assessing DNA-PKcs-bound DNA fragments at DSBs since a key step in Alt-EJ is initiation of end
resection. Aim 2: Define the role of telomere fusions for genomic instability during replicative crisis. The goal of
this aim is to understand the mechanisms of replicative crisis, as this is a crucial tumor suppressive proliferation
barrier. Cell death during crisis has been shown to be mediated by the proinflammatory cGAS/STING pathway
and activation of autophagy. Telomere fusions are a marker of cells undergoing crisis and have been shown to
activate the cGAS/STING pathway. Therefore, I hypothesize suppression of end synapsis, which causes
telomere fusions, can lead to decreased cGAS/STING activation and allow for cells to continue to replicate. To
test my hypothesis, I will use a replicative crisis cell line model and suppress telomere fusions by depletion of
end synapsis factors. With this model, I will examine telomere dysfunction, inflammatory and autophagy markers,
as well as cell survival. Overall, my scientific training at the Salk Institute in the Karlseder laboratory will provide
key skills and a strong foundation for my career as an independent researcher.

Public health relevance
Cellular senescence and replicative crisis are potent tumor suppressive proliferative barriers, such that understanding how cells bypass these barriers can give insight into cancer initiation and tumorigenesis. Telomere dysfunction plays a key role in such barriers and can be characterized by DNA double strand break mediated telomere fusions; therefore, it is critical to understand the mechanism of these telomere fusions and how they affect proliferative barriers. The proposed studies elucidate the role of DNA double strand break end synapsis factors during telomere fusions and replicative crisis and will support the mission of the NIH to understand the causes of cancer and improve cancer treatments for better patient outcomes.